Prostate Cancer Parasitism of the HSC "niche" as a Molecular Mechanism for Ost

In our previous P01 project we examined the relationship between the expression of CXCR4 by metastatic prostate cancers (PCa) and their bone homing behavior. From these studies we acquired data that suggest that not only do PCa's use the CXCR4/SDF-1 pathway to home to bone - but there is a strong likelihood they use the hematopoietic stem cell (HSC)

Public health relevance
Growth of prostate cancer in the bone is a common and serious late event of prostate cancer. Our proposed work will help define why prostate cancer can thrive in the bone including identifying key signals used for the establishment of prostate cancer metastases in bone. This work will help lay the foundations for evaluating therapeutic interventions.